Efficacy of an activities-based locomotor training program in children with cerebral palsy

PROJECT SUMMARY
Cerebral Palsy (CP) is a common lifelong neurological disorder affecting movement and posture, requiring
ongoing physical therapy to achieve functional gains. This project aims to evaluate the efficacy of an Activities-
Based Locomotor Training (AB-LT) program for young non-ambulatory children with CP, addressing the gap in
current research which primarily focuses on ambulatory children over six years old. AB-LT is designed to target
all three components of the World Health Organization’s International Classification of Functioning, Disability,
and Health (ICF) framework, incorporating partial body weight-supported treadmill training, overground
functional training, and play-based activities. This study will employ a randomized crossover design comparing
3 weeks of AB-LT with 3 weeks of usual therapeutic care in 19 children aged 2-6 years. Outcomes will be
assessed across the ICF framework using functional near-infrared spectroscopy (fNIRS) to measure
hemodynamic shifts in the prefrontal cortex, the Gross Motor Function Measure (GMFM-66) for gross motor
skills, and the Child Engagement in Daily Life (CEDL) for participation. The proposed study aims to determine:
1) hemodynamic shifts in the prefrontal cortex during functional movements following AB-LT compared to usual
care, hypothesizing improved regulation of the prefrontal cortex, and 2) changes in functional activity and
participation, hypothesizing greater improvements following AB-LT. The project aligns with the NICHD’s
mission to advance therapeutics for children with disabilities and will provide critical data to refine rehabilitation
strategies, influencing clinical practice by offering alternative, more efficient therapies. The study includes a
research mentoring component, engaging undergraduate and graduate-level PhD students, providing
opportunities in neuroimaging and rehabilitation research in children with CP. This multidisciplinary program
will involve up to four students over the project duration, enhancing their skills in clinical research and
evidence-based practice. This project will strengthen the research environment at Baylor University, preparing
future clinicians and researchers to contribute to advancing therapeutic interventions for children with CP.

Public health relevance
PROJECT NARRATIVE This project aims to improve the quality of life and functional outcomes for young non-ambulatory children with Cerebral Palsy (CP) by investigating the efficacy of an Activities-Based Locomotor Training (AB-LT) program compared to usual care. By targeting the body structures, activities, and participation components of the World Health Organization’s International Classification of Functioning, Disability, and Health (ICF) framework, this study seeks to enhance our understanding of neuroplasticity and motor learning in this population, offering a novel approach to rehabilitation. Results from this research will lead to more effective, individualized therapies that improve motor function, reduce disability, and ultimately lower the long-term healthcare needs associated with CP.